Spatial genomics single cell analysis of aging brains

Summary
We recently demonstrated a method called seqFISH+ that profiles >10,000 genes in single cells in intact brain
samples. seqFISH+ provides 10-fold or more improvement over existing methods in the number of mRNAs
profiled and barcodes detected per cell, providing a method to generate spatial atlas of cell. In this project, we
will apply seqFISH+ to the aging brain at P56, 9 month and 18 month of age for both males and females. We
will use the seqFISH+ data to map out cell-to-cell signaling interactions and their effects on cell fate decisions
directly in situ. With the genome coverage and spatial resolution of seqFISH+, it is now possible to perform
discovery-driven studies independent of scRNA-seq, allowing the interrogation of molecular processes in the
aging brain directly in situ. At the same time, we will develop the computational infrastructure to understand the
transition between different developmental time points at the single cell level. This highly innovative and
multidisciplinary approach will allow us to systematically generate a spatial atlas of the aging brain based on
anatomy and molecular identities. These collaborative efforts will allow us to break technological barriers and
develop an unprecedentedly comprehensive open resource for brain research.

Public health relevance
Narrative Understanding the aging brain at the single cell level is a major challenge and central to the goals of the NIA. We will use the newly developed seqFISH+ tools to profile the transcriptome in situ in brain slices from mouse brain at different ages. Application of this new technology to aging brains will allow us to study the cell type specific process occurring in young versus old brains.